BREATH - Breastfeeding, Early-life Microbiome and Respiratory Health Study

PROJECT SUMMARY
Significance: Childhood respiratory diseases pose a significant health burden and lack primary prevention
strategies. With genetics explaining only a fraction of the risk, the highly adaptable human microbiome is of
particular interest. Multiple studies have linked asthma and allergy to the early-life gut and nasal microbiome, yet
results are inconsistent and current studies have significant limitations. Thus, despite this great promise, the
clinical potential of the microbiome remains unfulfilled: robust microbiome-based asthma predictors and targets
for primary prevention are yet to be developed, and potential mechanisms underlying its involvement remain
elusive. Further, breastfeeding, a key determinant of infant microbiome development, is associated with reduced
childhood asthma rates, yet the intricate relationships between breastfeeding, microbiota development, and
respiratory health remain poorly understood. Here, I propose to combine state-of-the-art algorithms with large
longitudinal studies and animal models to elucidate the intricate mechanisms through which breastfeeding and
microbial colonization modulates early-life respiratory health outcomes.
Approach: This grant will leverage two established birth cohorts (CHILD and COPSAC; > 14,000 samples 16S,
shotgun metagenomic and metabolomics) to investigate early-life microbiomes, across two microbial niches,
alongside breastfeeding characteristics, human milk components and detailed clinical outcomes from birth to
early adolescent. We will first develop an unsupervised machine-learning tool for dimensionality reduction of
longitudinal multi-omics data to identify robust colonization patterns across microbial niches (Aim 1). Next, we
will identify microbial genetic adaptation and colonization patterns underlying childhood respiratory diseases. We
will use these to detect specific microbial functions and genetic regions associated with childhood respiratory
diseases, facilitating an investigation of potential mechanisms (Aim 2). Finally, we will determine the role of
breastfeeding and breastmilk as regulators of microbiome-asthma interactions. We will develop a causal
inference framework alongside an animal model of weaning and examine the microbial and immune response
to early weaning as well as lung resistance (Aim 3).
Innovation: This study represents a paradigm shift in research through several key innovations: (1) a dynamic
approach capturing microbial communities over time for more robust and reproducible results; (2) simultaneous
modeling of nasal/airway and gut microbiomes across large birth cohorts, revealing shared patterns; (3)
metagenomic sequencing, growth rates, structural variations, and selection metrics for population genetic
insights; (4) integration of human milk composition analysis; (5) a novel early weaning model; and (6) state-of-
the-art computational methods for precise multi-omics time-series analysis. Overall, by uniting large longitudinal
datasets with advanced algorithms and in vivo models, this research will advance our understanding of the
intricate links between the microbiome, breastfeeding, and childhood respiratory health outcomes.

Public health relevance
PROJECT NARRATIVE This project will combine large birth cohorts, state-of-the-art algorithms, and animal models to elucidate the intricate mechanisms through which breastfeeding and microbial colonization modulates childhood respiratory health outcomes years in advance. Our study will revolutionize the way breastfeeding and early-life microbial colonization are studied and understood and will provide a foundation for the development of robust microbiome- based asthma predictors and targets for primary prevention.